Testing Technology-Based Implementation Strategies for a Family-Based Pediatric Health Behavior Intervention in Community-Based Primary Care: A Cluster Randomized Factorial Trial

Project Summary/Abstract
Decades of research support the effectiveness of family-centered preventive interventions (FCPIs)in limiting
cardiovascular disease (CVD) risk for children. Pediatric primary care offers the ideal delivery system in which
to embed effective FCPIs for CVD risk given goal alignment, parents’ trust in and longitudinal contact with
pediatricians, and reach into communities facing CVD disparities. Despite endorsement from the United States
Preventive Services Task Force, few FCPIs have been widely implemented in primary care, resulting in limited
access for families and public health impact. This application focuses on facilitating the widespread
implementation of the evidence-based Family Check-Up 4 Health (FCU4Health), a FCPI with demonstrated
positive effects on family and child health behaviors. To test the FCU4Health, we conducted an RCT with 240
primarily Mexican American and low-income families in partnership with multiple primary care systems. Children
were ≥5.5 to <13 years old and had elevated BMI (≥85th percentile for age and gender) at their most recent
primary care visit. Compared to usual care, FCU4Health significantly improved child and family health behaviors,
child social-emotional health, and resulted in meaningful change in child BMI at a magnitude consistent with
other interventions. Given this positive evidence, integrated primary care organizations have become
increasingly interested in its adoption. Our universal prevention trial with 217 primarily Mexican American and
low-income families with a 2- to 5-year-old child is currently underway in an integrated primary care system.
During these two trials, with guidance from the RE-AIM framework, and a Community Advisory Board that has
overseen FCU4Health development and testing, several implementation barriers were identified affecting its
reach, fidelity, and engagement. Technology-based implementation strategies (a clinical decision support tool,
automated fidelity monitoring, and an Electronic Health Record (EHR)-integrated SMS text messaging platform)
were developed to promote delivery at scale. In the proposed biphasic study, the R61 phase involves integration
of these strategies with the EHR and usability testing. In the R33 phase, a hybrid type 3 cluster randomized
factorial trial will be conducted with 150 coordinators and 1200 families to examine effects of the strategies on
fidelity and engagement (primary implementation outcomes) and child health behaviors (primary clinical
outcomes), family health routines, parenting skills, and child BMI. Prospective implementation cost analyses will
be performed to examine the economic impact and cost-effectiveness of each strategy. Finally, we will model
trajectories of child and family health behaviors and examine the associations with BMI at the 18-month follow-
up. The large sample size will allow us to examine these associations by baseline characteristics (BMI,
developmental stage, race/ethnicity, and gender). Results have the potential for a significant public health impact
on CVD risk by facilitating the scale-up of effective interventions for families in primary care settings.

Public health relevance
Project Narrative Despite the demonstrated effectiveness of family-centered preventive interventions (FCPI) to prevent cardiovascular disease (CVD) risk factors during childhood, implementation barriers have led to their limited adoption in pediatric primary care. Two randomized effectiveness-implementation trials of the Family Check-Up 4 Health program conducted in several primary care systems have demonstrated significant positive effects on child and family health behaviors associated with CVD risk and have identified barriers to multiple implementation outcomes limiting scale-up and public health impact. Multiple implementation strategies developed in partnership with a standing Community Advisory Board will be integrated and tested in the proposed biphasic study to assess their effects on identified implementation barriers, with the goal of promoting widespread adoption and sustained implementation of family-based CVD prevention in primary care.